Epigenome-wide variations and socio-environmental exposures in African American asthmatic children

ABSTRACT
Asthma is a major public health problem in the United States, affecting 11 million children. Despite
advances in asthma care, African Americans (AAs) are 4 times more likely to be hospitalized and
5 times more likely to die from asthma than European Americans (EAs). Several factors could be
responsible for the observed asthma racial disparities including genetic and non-genetic factors.
While epigenetics appear to serve as a critical biological switch between genetic vulnerability and
socio-environmental exposures, limited studies are available that directly map the socio-
environmental exposures with asthmatic epigenome/genome information. In addition, current
approach do not leverage existing geospatial data such as environmental exposure and
neighborhood socioeconomic conditions to improve asthma risk prediction. In this proposal, we
will utilize comprehensive geocoding algorithms, novel statistical methods to integrate social,
clinical, environmental, genetic, and epigenetic data into a composite score for asthma risk
stratification and prediction. The overall objective of this research is to conduct genome-wide
Methyl-Seq analysis and leverage existing well-phenotyped AA pediatric asthma cohort with
extensive socio-environmental exposures and ancestry-tailored multi-ethnic genotyping array
(MEGA) data from Cincinnati Pediatrics Repository to accurately determine and develop ancestry-
specific asthma risk stratification and prediction models. The objective of this application is to
undertake an epigenome-wide association study (EWAS), incorporating geocoded neighborhood-
and individual-level socio-environmental predictors, and novel analytical strategies to create a
composite risk score incorporating methylation risk score (MRS), ancestry, environmental
exposures and social characteristics to predict asthma. We will accomplish these objectives
through the following Specific Aims: 1) Develop an ancestry-specific methylation risk score (MRS)
for asthma and test its association with socio-environmental exposures contributing to asthma
risk. 2) Determine the mediation effects of MRS between genetic ancestry and asthma risk. 3)
Develop a multivariable risk predictive model for asthma incorporating MRS, genetic ancestry,
clinical, and socio-environmental risk factors. The proposed research is innovative because this
will be the first time a MRS approach will be used to develop a population-based risk profile in
asthmatics. The study will provide insights in the use of risk stratification for screening and
targeted interventions. This work is significant because it can serve as a model to study the
composite effect of MRS, ancestry, socio-environmental, and clinical risk factors on racial
disparities in other well-documented common complex diseases beyond asthma.

Public health relevance
NARRATIVE The overall goal of this project is to decipher the epigenome and socio-environmental exposure determinants of asthma by carrying out genome-wide Methyl-Seq at more than 3.7 million CpG sites, incorporating geocoded neighborhood- and individual- level socio-environmental predictors and existing multi-ethnic genotyping array (MEGA) data, and using novel analytical strategies to create an ancestry-specific methylation risk score (MRS) followed by composite risk prediction by incorporating MRS, genetic ancestry, clinical, and socio-environmental exposure risk factors. The study will provide insights in the use of risk stratification in asthma and will likely provide a model composite risk system in other well-documented common complex diseases beyond asthma.